PATHOPHYSIOLOGY OF RENAL GU ANOMALIES IN UTERO COCAINE

This study seeks to assess renal glomerular and tubular functions, determine prevalence of renal-GU anomalies, and evaluate the long term effects of cocaine exposure to infants born to cocaine-using mothers. We hypothesize that: a) in-utero cocaine exposure during early pregnancy has a renal-GU teratogenic effect; b) cocaine-exposed infants demonstrate impaired GFR and/or renal acidification; c) the potential for renal growth is decreased in the cocaine-exposed infant.